Osteoinductive Nanosilicate-Based Biomaterials for In Situ Craniomaxillofacial Bone Regeneration

PROJECT SUMMARY
A range of synthetic bone graft substitutes loaded with therapeutic growth factors, such as recombinant human
bone morphogenetic protein 2 (rhBMP2), are used for reconstructing craniofacial bone defects in patients
suffering from trauma, infection, congenital anomalies, and oncologic resection. However, these strategies often
involve the administration of supraphysiological doses of growth factors, which have been reported to lead to
serious off-target tissue responses, including heterotopic ossification (bone formation at undesirable places),
osteolysis, and swelling. The objective of this proposal is to design osteoinductive biomaterials to induce in situ
bone regeneration in the absence of exogenous growth factors. This project builds upon the PI’s extensive
published and preliminary data on a new class of two-dimensional (2D) mineral-based nanoparticles, known as
nanosilicates, to induce osteogenic differentiation of human mesenchymal stem cells in the absence of growth
factors. Also, nanosilicate-based shear-thinning biomaterials can be used for minimally invasive cell therapy.
The central hypothesis is that nanosilicate-based biomaterials will activate endogenous cells to promote bone
formation in the absence of exogenous growth factors. To test this hypothesis three independent specific aims
are proposed: (1) Elucidate the molecular mechanism of nanosilicate-induced osteoinductivity; (2) Design 3D
printed nanosilicates-loaded microporous scaffolds for rapid cellular invasion and angiogenesis; and (3)
Demonstrate in situ bone regeneration using 3D printed nanosilicates-loaded microporous scaffolds. It is
expected that the ability of nanosilicate-based biomaterials to induce in situ bone regeneration by stimulating
endogenous cells will circumvent the current clinical limitations associated with the use of supraphysiological
doses of growth factors. The proposed research is significant because it will advance and expand the
understanding of how this new class of 2D nanomaterials can be used in bone tissue engineering. The
completion of the proposed work will provide a new class of osteoinductive biomaterials for future studies in
larger animal models and eventually advance bone regeneration approaches for humans.

Public health relevance
PROJECT NARRATIVE This proposal aims to design a new class of osteoinductive biomaterials for in situ bone regeneration in the absence of exogenous growth factor. The proposed approach will circumvent the current clinical limitations associated with the use of supraphysiological doses of growth factors. The completion of the proposed work will provide a new class of biomaterials for cranial bone reconstruction, and eventually advance bone regeneration approaches for humans.